Corticosteroids to Reduce Inflammation in Severe Pancreatitis (CRISP)

ABSTRACT
There are currently limited medicinal interventions demonstrated to improve outcomes in patients with acute
severe non-autoimmune pancreatitis, a highly morbid and potentially fatal condition which is estimated to afflict
up to 275,000 patients annually in the US.[1] Early-stage mild pancreatitis often self-resolves; however 15-20%
of cases [2] progress to a severe form characterized by a potentially lethal systemic inflammatory response
syndrome with injury to multiple organs and (frequently) respiratory failure. Further clinical deterioration can lead
to necrotizing pancreatitis, which is clinically similar to sepsis and has a reported mortality of up to 30%. [3–6]
Although inflammation is known to be a key driver of disease progression, no anti-inflammatory therapy
investigated to date has shown sufficient efficacy to become part of routine clinical practice. Identification
of a viable medicinal therapy for severe acute pancreatitis thus remains a significant unmet need. In this
application, we propose this need can be met via early delivery of a short course of physiologic-dose
corticosteroids. This commonly used anti-inflammatory therapy has been shown to provide a clear patient
benefit with other diseases which trigger systemic inflammation, multi-organ injury, and respiratory failure (e.g.
sepsis, Acute Respiratory Distress Disorder (ARDS), and most recently COVID-19), but has been poorly studied
in pancreatitis. The few published pilot trials of this therapy for severe acute pancreatitis have shown
corticosteroids shorten the duration of shock and may improve mortality, but these results must be validated in
a series of increasingly large, rigorous clinical trials before this therapy is widely accepted by clinicians. Here we
propose the logical first step Phase II trial: a blinded, randomized clinical trial of an early physiological dose
of hydrocortisone vs. placebo in 86 ICU patients with severe acute pancreatitis. The trial will be conducted
by the nationally recognized critical care research team at the Center for Resuscitation Science. We hypothesize
that corticosteroids will attenuate the inflammatory response from pancreatitis resulting in mitigated disease severity
and organ injury. We secondarily hypothesize there will be a concomitant reduction in mortality, though this hypothesis
will be the focus of a follow-up Phase III trial. After baseline assessments, enrollees will receive either 100 mgs of
hydrocortisone or matching placebo intravenously in a blinded fashion every 8 hours for 72 hours (300 mg/day).
The primary trial outcome will be the change in SOFA disease severity score over 72 hours, and from these data
we will conduct a novel sub-study to determine if corticosteroid efficacy is better in specific subgroups whose
clinical outcomes may be the most uncertain. Secondary outcomes will include progression to ARDS, ventilator-
free days, ICU- and hospital-free days, inflammatory biomarker profiles, biomarkers for pancreatic injury, and
adverse events. Overall, this study will provide an initial assessment of a commonly used, and effective anti-
inflammatory therapy as a treatment for a critical illness which generally lacks medicinal therapeutic options.

Public health relevance
NARRATIVE Pancreatitis is a common and potentially lethal and/or debilitating condition for which existing treatment options have shown limited efficacy. Since inflammation is a key driver of disease progression in pancreatitis, we propose to conduct a Phase II randomized clinical trial to establish if a brief course of anti-inflammatory corticosteroids given very early in the acute process will improve key clinical outcomes including illness severity, inflammation and pancreatic injury, hospital and ICU-free days, and death. Successful trial outcomes will set the stage for a larger multi-site Phase III trial and potentially lead to a new and effective treatment option for pancreatitis.